Studies on Protein Lipidation

? DESCRIPTION (provided by applicant): Lipid chemical reporters and bioorthogonal ligation methods developed by my laboratory have provided new opportunities to investigate the functions of lipid-modified proteins in biology. Our proteomic analysis of fatty-acylated proteins in dendritic cells using fatty acid chemical reporters and bioorthogonal chemical proteomics has revealed a new role for protein S-fatty-acylation in host defense against viral infections. We discovered that S-fatty-acylation of membrane-proximal cysteines on murine IFITM3 is crucial for its membrane localization and antiviral activity against influenza A virus. The mechanisms that control S-fatty-acylation of human IFITM proteins have not been evaluated and will be addressed in this grant proposal. Aim 1 will evaluate the S-fatty-acylation levels, sites and function of human IFITM isoforms in different cell types/states of activation. Aim 2 describes the characterization of fatty acids covalently attached to human IFITM3 in cells. Aim 3 describes site-specific lipidation and reconstitution of IFITM3 in vitro for detailed biochemical and biophysical studies. Determining the mechanisms that control S-fatty-acylation IFITM3 function is crucial for understanding host immunity and may reveal new strategies for combatting virus infection in humans. The chemical approaches described in this grant should provide new reagents and methods for studying fatty-acylated proteins.

Public health relevance
PUBLIC HEALTH RELEVANCE: This proposal describes chemical and biochemical approaches to characterize the roles of protein lipidation in host resistance to microbial infections. Our preliminary studies have demonstrated that S-fatty-acylation of interferon-inducible transmembrane proteins (IFITMs) is required for cellular resistance to influenza virus infection. How S-fatty-acylation controls human IFITM3 function is unclear and will be evaluated in this grant with new chemical biology tools, cell biology assays, in vitro protein biochemistry and infection studies.